1/1 INIA Stress and Chronic Alcohol Interactions: Administrative Resource

PROJECT SUMMARY
The consortium Integrative Neuroscience Initiative on Alcoholism: Stress and Chronic Alcohol Interactions
(a.k.a. INIAstress) is a collection of highly integrative and innovative projects and cores. The overarching
goal of INIAstress is elucidating the changes in brain circuitry and mechanisms that underlie how chronic
alcohol alters response to stress, which in turn can facilitate the transition from moderate/social drinking to
heavy/hazardous drinking and associated problems. The consortium has defined factors that contribute to an
individual's risk for the development of alcohol use disorder (AUD), revealed underlying mechanisms and
conditions that promote excessive and harmful drinking, and forged progress towards discovering more effective
and tailored treatment strategies. In the next renewal, the overarching goal of the INIAstress Consortium is to
apply cutting-edge technologies towards elucidating mechanisms of neural adaptation in key brain circuitry that
underlie how alcohol and stress interact to facilitate a trajectory toward excessive drinking, a negative emotional
state, cognitive (executive) function deficits, and harmful abstinence/relapse cycles. Through this knowledge the
consortium will advance personalized medicine approaches to facilitate recovery from AUD and, in particular,
stress-related excessive alcohol consumption. Collectively, these collaborative, cross-species studies directly
integrate behavioral, endocrine, neural, and genetic data within a scope of expertise and thematic inquiry
that would not be possible using more traditional grant mechanisms. As the lead application, the
Administrative Resource Core will provide scientific leadership on the consortium's main goals and serve as
a centralized administrative structure to facilitate and coordinate the overall management, direction and
integration of research activities within the INIAstress Consortium.

Public health relevance
PROJECT NARRATIVE This Administrative Resource Core of the consortium Integrative Neuroscience Initiative on Alcoholism: Stress and Chronic Alcohol Interactions (a.k.a. INIAstress) will provide oversight, direction and coordination of the 8 research projects and 2 research cores that collectively address brain circuitry and mechanisms underlying the reciprocal relationship of chronic alcohol and stress reactivity, with the overall goal of identifying new targets for effective pharmacotherapies to treat alcohol use disorders.